RP2_Harville

ABSTRACT/SUMMARY
In Louisiana, those living in parishes that lack access to maternal care, referred to as “maternity care deserts” experience a 91% increase in risk of death during pregnancy and up to 1 year postpartum. As obstetric care in these largely rural parishes is unlikely, there is a critical need to develop interventions that will improve maternal health care in these areas. The overall objective of this application is to examine the potential of enhanced remote care to improve maternal health. The overall hypothesis is that innovative models of care, based in local healthcare needs and service delivery context, can mitigate the lack of high-level services located in these areas. When patients live far from care sites, remote care has obvious advantages, reducing the need for long trips, limiting unnecessary care, and identifying problems earlier. Ochsner’s Connected MOM program (at-home blood pressure and weight monitoring) has been successfully implemented in southern Louisiana and been associated with a reduction in preterm birth. However, there are there are some groups of women who were less likely to benefit from the program. The project will be conducted in two phases: In the formative phase (years 1-2), the project goal is to establish local needs, relationships, and infrastructure to conduct a remote care intervention (Connected MOM+) that reflects locally identified healthcare delivery goals. This will be accomplished by presenting Connected MOM to community groups and determining the service needs, technological challenges, and barriers to implementation of the intervention, via interviews and focus groups. Implementation phase project infrastructure, including protocols, manuals of procedures, data collection tools, provider training, digital infrastructure, and staffing, will then be created. In the implementation phase (years 3-7), a hybrid effectiveness-implementation study will be conducted, testing implementation, process, and health outcomes of the enhanced remote care package across 27 parishes in northern Louisiana. Access to care, health, and implementation outcomes (reach/adoption/fidelity) will be examined via the electronic health record system, and patient satisfaction and implementation outcomes (acceptability/appropriateness) assessed in a sample. This project will have an important positive impact by improving the health of populations with limited access to maternal healthcare services.

Public health relevance
Public Health Relevance Statement/Project Narrative This project will provide a strong paradigm for implementing a remote monitoring program to prevent maternal complications and improve access to care in maternity care deserts and low-access areas, consistent with the IMPROVE initiative’s goal of reducing preventable causes of maternal deaths and improving health for women before, during, and after delivery.